Elucidating the regulation and spread of an integrative and conjugative element from Streptococcus mutans in the oral microbiome

Project Summary/Abstract
Microbial evolution is dominated by horizontal gene transfer (HGT), which is prevalent in bacterial biofilms
such as dental plaque. HGT is often mediated by conjugative elements, mobile genetic elements that encode
machinery to transfer the element from a host (donor) cell to a recipient cell, thereby generating a new
bacterial host. Integrative and conjugative elements (ICEs) appear to be the most prevalent type of conjugative
element and some mediate genetic exchange between diverse bacterial species. ICEs play a critical role in the
spread of virulence traits and antibiotic resistances within multidrug resistant pathogens. ICEs, or putative
ICEs, are prevalent in oral bacteria. Streptococcus mutans, a major causative agent of dental caries, contains
an uncharacterized ICE TnSmu1. This proposal undertakes the first characterization of TnSmu1 as a model of
HGT within this critical oral pathogen. The data show that TnSmu1 is a functional ICE: It can excise from the
host chromosome and transfer to recipient cells. The physiological function(s) of TnSmu1 and its ability to drive
HGT in the oral cavity are unknown. This study tests the hypothesis that TnSmu1 activation is affected by host
physiological signals and TnSmu1 presence in oral Streptococci allows increased survival in oral communities.
This proposal will elucidate the regulation and fitness attributes of TnSmu1 and its ability to transfer to
other members of the oral microbiome. Two transcription factors, CovR and SloR, encoded by S. mutans (i.e.,
not in TnSmu1), control many virulence genes involved in caries formation and bind the predicted regulatory
region of TnSmu1. This study examines if these factors link the pathogenic attributes of S. mutans to its role in
HGT. This proposal will investigate the role of CovR and SloR and the physiological conditions that regulate
them on the excision and transfer of TnSmu1. This work tests the ability of TnSmu1 to spread within the
diverse oral communities of dental plaque, transferring itself and other mobile genetic elements to different oral
bacterial species. It will also define the cost/benefit of TnSmu1 to its host cells, as its presence may impact S.
mutans fitness in the oral cavity. At the conclusion of these studies, this work will have created a new
understanding of HGT, evolution, and pathogenesis of S. mutans within the oral microbiome. Additionally, this
work will result in tools to genetically manipulate many oral microbes that lack robust genetic systems.
The fellowship training plan provides the fellow with training in bacterial genetics while leveraging the
fellow’s background with host pathogen interactions. Dr. Grossman (sponsor) is a renowned bacterial
geneticist and molecular biologist that has >30 years of mentorship experience as a professor with many
postdoctoral trainees obtaining independent research positions. The research environment in this lab and
within the Massachusetts Institute of Technology serves to address the aims of the research proposed and to
aid in the applicant’s development as an independent researcher and long term as an academic professor.

Public health relevance
Project Narrative Mobile genetic elements can transfer between cells in a microbial community and contribute significantly to the spread of antibiotic resistances, virulence determinants, and metabolic capabilities. Although widespread within oral microbial communities, fundamental aspects of the elements and mechanisms that drive horizontal gene transfer within dental plaque remain poorly understood. This work is focused on an integrative and conjugative element (a type of mobile element that is transferred from cell to cell via conjugation) found in the genome of the oral pathogen Streptococcus mutans, determining the effects of this element on S. mutans physiology and its ability to transfer to other bacteria in the oral microbiome.